Tissue and organ specific human B cell immunity: Supplement - Metabolic Risk Factors and Inflammation in PASC Development

Although coronaviruses are typically believed to cause acute respiratory infections, emerging evidence suggests
that viral antigen or perhaps even intact virus may be found outside of the respiratory system for extended
periods of time following acute infection. Moreover, the data show that numerous non-respiratory tract tissues,
including adipose tissue, can serve as a reservoir for the virus, suggesting that this infection may have long-term
effects on multiple organ systems of the body. It is now recognized that a significant fraction of individuals
diagnosed with COVID-19 will continue to exhibit a wide array of debilitating symptoms, collectively referred to
as Post-Acute Sequalae of SARS-CoV-2 (PASC or Long-COVID), for weeks to months after infection. Given the
enormous number of SARS-CoV-2 infected individuals who are likely to develop PASC, there is a critical need
to better understand the risk factors associated with the different PASC manifestations and to develop
appropriate interventions to treat these patients. To date, we know very little about the causes of PASC and do
not have any understanding of whether pre-existing health issues (risk factors) can be used to predict whether
someone will develop PASC or whether individuals with particular risk factors will develop PASC with a specific
set of symptoms. The goal of this supplement is to determine whether metabolic changes associated with pre-
existing obesity and Type II Diabetes (T2D) contribute to specific PASC-associated immune manifestations. In
this supplement, we will test the hypothesis that metabolic risk factors can be used to identify patients with an
inflammatory PASC syndrome that is characterized by persistent immune activation. To meet these goals, we
have assembled >4000 consented participants (Enterprise cohort) who were previously hospitalized for COVID-
19 infection. We have access to their electronic medical records, can follow their symptoms longitudinally with
on-line questionnaires and can obtain biologic samples from them. We have bio-banked blood samples, collected
during the acute infection, from >1700 individuals, many of whom were diagnosed with PASC and have been
followed longitudinally in our PASC clinic. Using these samples as well as additional blood samples that will be
collected from PASC patients in the Enterprise cohort, we propose to: (i) determine whether obese and T2D
PASC patients exhibit sustained anti-viral T and B cell responses; (ii) examine whether metabolic risk factors
and inflammatory mediators linked to obesity and T2D correlate with the development of inflammatory PASC;
and (iii) assess whether pre-existing obesity and associated metabolic disease predict the development of an
inflammatory PASC syndrome. These studies are important as they will allow us to specifically interrogate the
metabolic and immunologic factors that influence the pathophysiology of PASC in individuals with chronic co-
morbidities that affect a large proportion of the population in the Deep South. In the future, we expect that insights
gained from these studies may improve the PASC diagnosis and treatment.

Public health relevance
Project Narrative More than 300 million people worldwide have been infected with SARS-CoV-2 and more than 5 million people have died over the last two years from this virus. Of those who recover from the infection, it is estimated up to 30% continue to suffer with long-term symptoms referred to as Long-COVID or Post-Acute Seqelae of SARS- CoV-2 (PASC). The goal of this proposal is assess whether specific health factors, including obesity, cardiometabolic syndrome or diabetes, alter the immune system response to SARS-CoV-2 and increase the risk of developing PASC.